Learning to represent time in striatal circuits

Project Summary
Learning to predict the time of salient environmental stimuli, such as rewards, is essential for survival. During
classical conditioning, animals learn when to expect a rewarding stimulus (e.g., food) following a predictive cue
(e.g., odor). The striatum is implicated in associative reward learning, movement, and timing. Furthermore, the
predominant striatal neuron types, medium spiny projection neurons (MSNs) expressing dopamine receptor type
1 (D1) or 2 (D2), both contribute to these diverse behavioral functions. However, the specific roles of D1 and D2
MSNs in learning to represent time are unknown. The research goal of my training grant is to elucidate how
temporal coding by ventral striatal D1 and D2 MSNs evolves during learning and the extent to which these distinct
cell types contribute to the learning of timed motor behavior. My central hypothesis is that (1) learning improves
D1 and D2 MSN temporal coding in response to a reward-predictive cue, and (2) D1 and D2 MSNs exhibit
opposing, complementary roles for learning to initiate precisely timed movements. To test this hypothesis, I will
utilize a classical conditioning behavioral paradigm in which mice learn to lick in anticipation following a reward-
predictive cue. In either the early or late stages of learning, I will use in vivo electrophysiological recordings from
optogenetically identified D1 and D2 MSNs, behavioral assessment of the effect of perturbing these cell types,
and computational methods to decode time from neural population activity. In Aim 1, I will record D1 and D2
MSN dynamics in different stages of learning and decode time using a machine learning-based pattern classifier.
Aim 1 analyses will make comparisons of temporal decoding performance between D1 and D2 MSNs, early and
late stages of learning, and distinct temporal intervals. In Aim 2, I will elucidate the causal roles of D1 and D2
MSN activity for learning to produce precisely timed, reward-conditioned licking movements. I will optogenetically
inhibit the activity of D1 or D2 MSNs throughout classical conditioning, and I will determine the extent to which
these perturbations impact the execution of conditioned licking behavior (e.g., lick initiation time and lick
probability). The expected outcomes are that perturbing D1 and D2 MSN activity throughout learning will impair
both the temporal precision and mean time of cue-evoked lick initiation. Specifically, I expect that there will be
differential effects of D1 and D2 MSN perturbations, such that inhibition of D1 and D2 MSNs increases and
decreases mean lick onset time, respectively. These outcomes would suggest that a precise balance of D1 and
D2 MSN activity underlies behavioral timing during associative learning. Overall, this project will provide insights
on the temporal nature of how the brain processes reward during experience-dependent learning.

Public health relevance
Project Narrative Learning to track elapsed time is a cornerstone of cognition and behavior, enabling animals to anticipate events, coordinate precise movements, and effectively sequence actions. This fundamental skill is often perturbed in disorders such as Parkinson’s disease, which is characterized by impaired temporal perception. The striatum is an essential locus for temporal processing in both health and disease and, thus, this project will provide critical insights to the physiological mechanisms underlying timing behaviors.